Mali ICEMR Project 1: The Epidemiology of Malaria Control Strategies

PROJECT 1 SUMMARY
Wide deployment of malaria control tools in the past decade, has significantly contribute
to substantial reduction of the incidence and deaths related to the disease in Sub-sahara
Africa (ref). Yet, the region continues to carry a disproportionately high share of the global
malaria burden of malaria deaths. Moreover incidence remains high but stable in some
settings while rebounding in others after a long period of decrease associated with
intensive deployment of malaria control tools. The gap in our knowledge that this project
will fill is information on the relationships interaction among current combination of malaria
control interventions, entomologic aspects of transmission and the incidence of human
infection and disease in different eco-zones across West Africa that span the savanna and
sub-Saharan Sahel region. The goal of this project is to understand why different
patterns of malaria epidemiology and endemicity are resilient to current control strategies
at four sites in Mali. The four field sites exhibit different endemicities, length of seasonality,
and different combinations of control interventions and duration of implementation of those
interventions. The specific aims are 1] Determine a cohort-based long-term effect of
concurrent malaria control interventions on the incidence of uncomplicated and severe
malaria in relation with asexual an sexual malaria infections at 4 ecological settings with
different combination of malaria control interventions in West Africa; 2] Determine
seasonal changes in malaria vector population composition, biting behavior and
sporozoite rates in relation with ongoing vector control tools deployed on each ecological
setting; 3] Assess the relationships between temporal and spatial variations in vector
epidemiological parameters, and P. falciparum infection and disease in human
populations. This project links the different aspects of malaria transmission and disease
into a unified whole, adding the ability to distinguish the contributions of different malaria
control interventions on parasite population and range of immune responses (Project 2,
Immunopahtogenesis) and seasonal and geographical distribution of Anopheline
mosquitoes vectors (Project 3). Understanding the factors relating entomologic and
epidemiological patterns of transmission will provide more definitive guidelines for malaria
control efforts in Mali and in West Africa.